IONIZING RADIATION INDUCED DNA DAMAGE AND REPAIR

The goal of this project is to explain how ionizing radiation causes cancer, mutation and cell death by elucidating the chemistry and enzymology of X-ray-induced DNA damage and repair in human cells. New approaches to the study of X-ray-induced single-strand breaks and base-modifications are described. We will use a repeated sequence (alpha sequence) in human DNA to 1) determine the location (sequence) of strand breaks after gamma-irradiation in vitro and in vivo; 2) determine the effect of oxygenation, pH, temperature, and free radical scavengers on the location and extent of strand breaks; 3) determine the location (sequence) of alkali-labile sites in gamma-irradiated DNA; 4) determine the level of production of a newly described X-ray lesion, 3' phosphoglycolate termini, in DNA irradiated in vitro and in intact cells. The approach to study of X-ray induced base modifications uses a sensitive "post-modification labeling" method. This method will be used to determine 1) levels of formation of particular base-modifications after gamma-irradiation and 2) the rates and extent of repair of such base-modifications after gamma irradiation. The approach chosen to study human repair enzymes uses DNA substrates which contain single, defined and radiolabeled lesions of the types induced by X-rays. We will 1) determine the presence of human enzymes specific for DNA containing thymine glycols, HMU and 3' phosphoglycolate termini; 2) utilize such substrates for isolation and characterization of such enzymes; 3) determine whether a deficiency of such an enzyme can explain the susceptibility of ataxia telangiectasia cells to X-rays and radiomimetic drugs. Knowledge of the processes of X-ray DNA damage and repair will be useful in developing more rational approaches to cancer prevention and therapy and in predicting the effects of low level radiation exposure.